Adipokine Signaling in Melanoma: Unmasking the Obesity Paradox.

Project Summary/Abstract
Background: Studies have revealed that obese individuals have longer survival on BRAF-targeted therapy
(BRAF/MEKi) when compared to those with normal weight. This phenomenon, termed the "obesity paradox,"
remains without a mechanistic explanation.
Hypothesis/Objective: Our goal is to uncover the mechanisms behind the obesity paradox in melanoma and
identify therapeutic targets. We propose that adiponectin, a key adipocyte-secreted adipokine, plays a crucial
role by increasing fatty acid uptake within the tumor microenvironment (TME). In obesity, adiponectin levels are
reduced compared to normal weight individuals. We hypothesize that adiponectin decreases the effectiveness
of BRAF/MEKi by increasing melanoma tumor fatty acid uptake in the TME.
Specific Aims: In Aim 1, we will characterize the role of adiponectin within the TME of melanoma tumors in
obese and non-obese mice and assess changes following treatment with BRAF/MEKi. In Aim 2, we will
determine how sodium-glucose co-transporter 2 (SGLT2) inhibition alters adiponectin release, fatty acid
utilization and affects BRAF/MEKi responses.
Study Design: We will employ a diet-induced obesity (DIO) model in C57BL/6J mice implanted with
YUMMER1.7 cells to compare adipokine release, fatty acid oxidation, adipocyte transcriptome, and immune
responses between obese and non-obese mice treated with BRAF/MEKi. We will use an adiponectin knockout
mouse model to explore the role of adiponectin through exogenous delivery versus its absence under similar
conditions. Lastly, we will evaluate BRAF/MEKi responses in the DIO model coupled with SGLT2 inhibition, a
common diabetes medication with effects on fatty acid oxidation.
Impact: Our project diverges from conventional research by focusing on obesity as a favorable condition to
emulate. We will elucidate how obesity alters the TME and how adiponectin affects melanoma responses to
BRAF/MEKi. We anticipate discovering a unique therapeutic target that can be quickly translated into clinical
practice.
I firmly believe that the National Cancer Institute Early-Stage Surgeon Scientist (ESSP) program is tailor-made
for my career advancement as a surgeon scientist. This program's comprehensive research training,
professional development, and abundant resources will significantly accelerate my path to research
independence. By participating in the ESSP, I aim to swiftly transition into a role as a principal investigator
dedicated to research with direct implications for patient care and help further nurture other future surgeon
scientists.

Public health relevance
Project Narrative Our study investigates the “obesity paradox” in melanoma, the finding that obese individuals have improved survival compared to normal weight individuals, by examining adipokines, specifically adiponectin and its influence on melanoma response to BRAF targeted therapy. We also explore the impact of SGLT2 inhibition on adiponectin release and lipid metabolism, with the goal of enhancing BRAF targeted therapy responses by reducing free fatty acid availability in melanoma tumors. This project has the potential to improve melanoma treatment strategies by integrating targeted and metabolic therapies, benefiting a broader range of cancer patients.